Diagnostic markers of language impairment in bilingual adults

DIAGNOSTIC MARKERS OF LANGUAGE IMPAIRMENT IN BILINGUAL ADULTS
PROJECT SUMMARY
Aphasia, which refers to language impairment following focal or degenerative brain injury, has a
debilitating effect on a person’s quality of life due to its social, emotional and financial
repercussions. A significant proportion of persons with aphasia are bilingual, given that nearly
one-fifth of the U.S. population and over one-half of the world’s population is bilingual. The
overlap in language behaviors between bilinguals of varying proficiency and persons with
aphasia makes the diagnosis of bilingual aphasia particularly challenging. Yet, there are hardly
any psychometrically valid diagnostic instruments to diagnose aphasia and differentiate it from
the language variation seen across bilinguals. Over two-thirds of clinicians in the U.S. report
being unprepared to assess bilingual adults due to unavailability of valid diagnostic tools and
insufficient understanding of bilingual language disorders. The proposed research represents
the first systematic psychometric investigation of clinical language measures in English for
Spanish-English speaking bilingual adults across multiple language domains. The project will
establish language measures, population norms and cut-off scores with a three-fold purpose:
identification of aphasia, diagnosis of morphosyntactic and lexicosemantic impairments in
aphasia. The outcomes of this project will improve diagnostic accuracy and therefore reduce
health disparities for bilingual adults with aphasia.

Public health relevance
DIAGNOSTIC MARKERS OF LANGUAGE IMPAIRMENT IN BILINGUAL ADULTS PROJECT NARRATIVE Language variation in bilingual speakers poses significant challenges in diagnosing and subtyping aphasia which results from brain injury. The proposed research represents the first systematic psychometric investigation of clinical language measures for Spanish-English speaking bilingual adults across multiple language domains. The outcomes of this project will improve diagnostic accuracy and therefore reduce health disparities for bilingual adults with aphasia.